Evaluating maternal and newborn health disparities at the intersection of race, ethnicity, and disability in the U.S.

PROJECT SUMMARY
Women with disabilities experience pregnancy at the same rate as women without disabilities but have relatively higher rates of negative outcomes including pregnancy, labor and delivery complications, severe maternal morbidity, maternal death, preterm birth, stillbirth, low birth weight, and infant mortality rates. Although there is limited information about the extent of race and ethnicity-associated disparities in maternal and newborn health outcomes among women who are disabled, current evidence suggests that these disparities could be even more pronounced among racial and ethnic minorities compared to their White counterparts. Developing effective interventions to eliminate these disparities requires a comprehensive understanding of the relationships between these multiple levels of risk and associated birth outcomes. This project aims to fill this research gap using linked maternal-infant Medicaid claims, natality, and mortality data files. Three research aims are proposed. Aim 1 focuses on the magnitude of race and ethnicity-associated disparities in low birthweight, small for gestational age, preterm birth, and neonatal mortality among women with disabilities; Aim 2 evaluates the extent to which disparities in these outcomes are moderated by area-level determinants; and Aim 3 evaluates the association between race, ethnicity, and disability in nationally established quality measures for maternal-infant health. The proposed aims are supported by the PI’s career training goals, which include developing expertise in 1) using Medicaid claims data to produce measures of birth outcomes by race, ethnicity, and disability, 2) analyzing area-level determinants and quality of care measures associated with maternal and newborn health disparities, and 3) understanding disability measurement, public insurance coverage, risk factors for poor health, and community priorities needed to design effective interventions to reduce the prevalence of negative maternal and infant health outcomes in this population. The proposed project supports the PI’s long-term career goal to become an independent investigator and advocate for maternal and newborn health in the U.S., with a particular emphasis on using rigorous methodologies. Career development will include a series of formal courses, training workshops, and directed readings that will be completed with faculty at Dartmouth and other institutions over the first two years with additional topics covered as needed in the subsequent years. Attendance at conferences and related workshops will also be added to stay informed of current developments in the field. The award will be followed with a Research Project Grant (R01) to develop and test an intervention to improve outcomes among those with the highest prevalence of disability-associated negative pregnancy and birth outcomes in the U.S.

Public health relevance
Public Health Relevance In this K01 Career Development Award, I will lead an in-depth study of risk factors associated with poor maternal and newborn health outcomes in a Medicaid population with disabilities in Texas to better understand the disparities faced by this population with respect to race and ethnicity, area-level socioeconomic conditions, and quality of healthcare. This study will include women and their newborns across an urban-rural continuum and varied socioeconomic environments with a comprehensive assessment of low birthweight, small for gestational age, preterm birth, neonatal mortality, and four quality of care indicators. The findings will add to our knowledge of negative birth outcomes among women with disabilities in the U.S. and inform targeted interventions and policies aimed at reducing the maternal and newborn health disparities experienced by this population.